Halolipid-Neutrophil Extracellular Trap Axis in Halogen Lung Injury

Exposures to chlorine (Cl2) and bromine gases (Br2) are public health threats. Cl2 and Br2 exposures occur as a
result of industrial accidents as well as in chemical warfare. Cardiopulmonary failure is a major concern
following exposures, which contributes to mortality and morbidity; but the mechanisms underlying end organ
injury after exposure to Cl2 or Br2 remain to be determined. We discovered that Cl2 and Br2 gas exposure target
host plasmalogen lipids, resulting in high levels of 2-halofatty aldehyde and 2-halofatty acids in the lung and
circulation. Recently, we have shown 2-chlorofatty acids, at levels found in the plasma of mice and rats
exposed to Cl2, elicit neutrophil extracellular trap (NET) formation. Since NETs are critical and early initiators of
coagulopathies that cause end organ injury, the proposed studies will test the hypothesis that Cl2 and Br2
derived 2-halofatty acids elicit NET formation to induce lung injury. Furthermore, our preliminary data show 2-
bromofatty acid also causes NET formation, underscoring the potential for NET formation as a unifying
mechanism mediating both Cl2 and Br2 gas toxicity that will identify common therapeutic targets and
countermeasure development opportunities. Moreover, while Cl2 and Br2 are similar, their unique
physicochemical properties endow differences in mechanisms by which each cause injury. Salient to this
proposal, we have shown that 2-bromofatty aldehyde reactivity with nucleophiles is 25-fold greater than that of
2-chlorofatty aldehyde. In addition to testing the role of NET formation, proposed studies will also identify
protein targets of 2-bromofatty and 2-chlorofatty aldehydes and their respective 2-halofatty acids in mediating
NET formation, and we anticipate results from these studies will demonstrate overlapping and unique targets in
the pathways by which Cl2 and Br2 mediate circulatory and pulmonary dysfunction.
There are two specific aims for the proposed studies.
Specific Aim 1 will identify chlorolipids and bromolipids as critical mediators of NET formation and subsequent
lung injury following Cl2 and Br2 exposure.
Specific Aim 2 will identify mechanisms by which chlorolipids and bromolipids elicit NET formation in human
neutrophils.
We will employ both mouse and rat models of Cl2 and Br2 gas exposure. This, together with testing two distinct
toxicants at LD50 levels, meet criteria for this RFA. Collectively, the proposed studies will delineate a common
mechanism for Cl2 and Br2 toxicity mediated by halolipid-stimulated NET formation and organ failure. This
mechanism could lead to a common treatment for both of these Chemical Countermeasures Research
Program concerns in the future.

Public health relevance
The proposed studies will demonstrate a shared mechanism for halogen gas toxicity mediated by 2-halofatty acid-elicited NET formation. Demonstrating this pathway for both Cl2 and Br2 exposures may lead to the future development of a common therapeutic countermeasure.